Mechanisms of Ethnic/Racial Differences in Lung Cancer Due to Cigarette Smoking

ABSTRACT
Lung cancer is the leading cause of cancer death in the U.S. This renewal application for years 11-15 of our
Program Project Grant entitled “Mechanisms of Ethnic/Racial Differences in Lung Cancer Due to Cigarette
Smoking” brings together our team of renowned experts in cancer molecular epidemiology, tobacco control,
mechanisms and biochemistry of tobacco carcinogenesis, and biostatistics to continue our groundbreaking
research on biochemical, molecular, and epigenetic mechanisms by which cigarette smoking causes lung
cancer. We will build on our significant findings from ongoing studies which include important advances in the
epigenetics of lung cancer, biochemistry of nicotine leading to addiction and cancer, DNA damage by tobacco
smoke carcinogens including acrolein and 1,3-butadiene, and tobacco carcinogen biomarker studies which
expand and explain the dramatic differences in lung cancer incidence among cigarette smokers from 5 ethnic
groups – African Americans, Native Hawaiians, Whites, Latinos, and Japanese Americans. Project 1, “Genetic
and epigenetic risk markers for lung cancer in former smokers” proposes to identify these markers of lung
cancer risk in people who have quit smoking and improve our understanding of the ethnic/racial differences in
lung cancer risk among former smokers. Project 2, “CYP2A6 genetic score, nicotine metabolism, and lung
cancer” will focus on the primary catalyst of nicotine metabolism which is critical because people with low
activity of this enzyme smoke fewer cigarettes and smoke those less intensely because they need less
nicotine, which is proposed to lead to lower lung cancer risk. Project 3, “Untargeted adductomics to
characterize ethnic differences in the exposome of smokers” hypothesizes that biological responses towards
cigarette smoke exposure differ among individuals and ethnic groups due to genetic and/or epigenetic factors
that lead to differences in metabolic and inflammatory responses to smoking. Project 4, “Carcinogenesis
biomarkers in former smokers of the Multiethnic Cohort Study” will use a unique approach to determine the
metabolic activation of polycyclic aromatic hydrocarbons as well as lipid peroxidation in the lungs of former
smokers compared to never smokers. These 4 projects will be supported by 3 outstanding Cores:
Administrative Core, Clinical and Biomarkers Core, and Biostatistics Core. Thus, our experienced investigators
propose to continue their superb and unique teamwork to make significant progress in understanding lung
cancer mechanisms among present and former cigarette smokers leading to new insights for prevention of
fatal lung cancer.

Public health relevance
PROJECT NARRATIVE This program brings together highly respected scientists with expertise ranging from epidemiology and biostatistics to molecular aspects of tobacco control to determine why lung cancer risk from cigarette smoking is significantly different among five diverse ethnic/racial groups. The multidisciplinary team in this program follows this important lead to determine new approaches toward prevention of lung cancer, the leading cancer killer in the U.S.